Defining optimal tacrolimus dosing and concentrations in the early post-lung transplant period based on short- and long-term clinical impacts

PROJECT SUMMARY/ABSTRACT
Lung transplantation can be lifesaving for patients with advanced lung disease, but outcomes lag far behind
those of other major solid organ transplants in part due to complications such as acute cellular rejection (ACR),
acute kidney injury (AKI), and chronic kidney disease (CKD). Lung transplant recipients are particularly at risk
for insults in the early post-transplant period, characterized by critical illness and complications that may
significantly impact long-term transplant success. Perioperative dosing of the nephrotoxic immunosuppressant
tacrolimus (tac), used in 90% of lung transplant recipients to prevent allograft rejection, may be a target to
improve complication rates and long-term outcomes. We showed in an international survey of lung transplant
clinicians that early post-transplant tac dosing, timing of initiation, and target concentrations, for which there
are no consensus guidelines, vary widely across centers. Survey respondents also expressed broad concern
about both AKI and ACR risk related to perioperative tac levels. Data that could inform early dosing practices
to balance risk to allograft and kidneys are limited. Our small single-center study showed that AKI risk rose with
high early tac levels, but ACR findings were inconclusive. We found that uniform initial tac dosing with trough
monitoring (an approach used by 78% of our survey respondents) led to out-of-range levels on 73% of days 1-
14 post-transplant, and that genetic and clinical factors could predict 42% of tac concentration:dose variability.
Thus, target levels to minimize risk remain unclear and current practices fail to achieve targets. Robust studies
to quantify risk and improve tac concentration:dose prediction could impact lung transplant clinical practice.
We propose studies to bridge this crucial knowledge gap by leveraging the resources of the Lung Transplant
Outcomes Group (LTOG), an NIH-funded multicenter prospective cohort designed to study acute and long-
term lung transplant complications. The 6 LTOG centers in this proposal have enrolled >1400 patients since
2014 and are uniquely suited to rigorously study early tac exposure to inform the balance between short- and
long-term nephrotoxicity and allograft rejection. We hypothesize that tac exposure during the first 2 weeks is
associated with both short- and long-term transplant complications, and that genetic and clinical variables can
inform a personalized early tac dosing algorithm to minimize variability around an optimal target range. Adding
further clinical data, genotyping, and prospective population pharmacokinetic (popPK) modeling studies to the
existing resources of the LTOG, we aim to: 1) Determine risk of AKI, CKD, and ACR associated with tac
exposure during the first 2 weeks after lung transplantation, and 2) Derive and validate a popPK model of tac
exposure during the early transplant period to inform a personalized, clinically usable dosing algorithm.
Completion of these aims will clarify risks associated with perioperative tac dosing in the highly vulnerable lung
transplant population and provide a usable clinical tool to accurately individualize dosing, which in combination
will have the potential to reduce allograft and kidney complications and maximize long-term transplant success.

Public health relevance
PROJECT NARRATIVE Lung transplantation is the only effective treatment option for many people with advanced lung diseases such as emphysema, pulmonary fibrosis, and cystic fibrosis, but the critical immunosuppressive medication tacrolimus, needed to prevent rejection of the transplanted organ, has known toxicities such as acute kidney injury (AKI) and chronic kidney disease (CKD). Tacrolimus exposure during the high-risk early post-transplant period may contribute to such toxicities, yet there are limited data to inform target levels that best balance risks to the kidneys and transplanted lungs, perioperative dosing practices and target levels are highly variable across centers, and current trial-and-error dosing strategies result in unacceptably high frequency of supra- and sub-target concentrations during this vulnerable time period. The research outlined in this proposal will use a large, National Institutes of Health-funded multicenter lung transplant cohort to clarify the impact of early tacrolimus levels on AKI, CKD, and transplant rejection, define optimal early target levels that balance these complication risks, and construct a personalized dosing model based on genetic and clinical predictors of tacrolimus levels during the first two weeks after lung transplantation.